Identifying Epigenetic, Chromatin, and Transcriptomic landscapes to Improve SCNT Development in an Animal Model

PROJECT SUMMARY
Somatic cell nuclear transfer (SCNT) allows for the creation of genetically identical animals for
agricultural purposes, and is a powerful tool for production of genetically engineered animals for biomedical
applications and generation of patient-specific embryonic stem cells (SCNT-ESCs) for therapeutics. However,
the low efficiency of full term development limits its wide-spread use and practical utility. The fundamental
problem is how the egg incompletely reprograms a somatic donor nucleus. The overall objectives of the
current proposal are outlined in the two Specific Aims : 1) Identify epigenetic, chromatin, and transcriptomic
landscapes in in vitro fertilized (IVF) embryos and then elucidate how SCNT embryos deviate from this
developmental paradigm; and 2) Establish and test new approaches to correct reprogramming defects and
improve SCNT development both in preimplantation and postimplantation embryos. We have created high-
quality open chromatin maps for carefully-staged IVF and SCNT bovine embryos and leveraged cutting-edge
single-cell open chromatin profiling to clarify intra- and inter-embryo heterogeneity in chromatin
reprogramming. These maps allow us to interrogate, for the first time, how specific regions of the
genome open and close during normal preimplantation development, and how SCNT embryos deviate
from this paradigm. Our preliminary data clearly indicate early cleavage staged SCNT embryos do not
establish open chromatin properly, and implicate an important contributor to EGA, a transcription factor (TF)
DUX, as a major deficiency in SCNT embryos. We hypothesize that failures in chromatin reprogramming
during SCNT preimplantation development manifest later in postimplantation development, and that targeted
intervention using TF expression or preimplantation screening will improve SCNT developmental success. Aim
1 consists of three subaims: 1.1. Determine sex-specific SCNT open chromatin regions that deviate from IVF
embryos, or exhibit sex-specificity; 1.2. Identify somatic memory in SCNT embryos that is resistant to
reprogramming using DNA methylation profiling; and 1.3. Identify gene expression differences between SCNT
and IVF blastocysts and evaluate if they are biased towards ICM or TE lineages. Based on these data, we will
use bioinformatic analyses to identify additional TFs/regulators for further mechanistic dissection. In Aim 2,
three subaims will be tested: 2.1. if ectopic enforcement of EGA (using DUX and other TFs) can reactivate the
EGA program in cultured fibroblasts; 2.2. If targeted activation of the EGA network in SCNT embryos using TF
or TF combinations (from 2.1) would improve reprogramming and facilitate their development and 2.3. If single-
cell biopsy and open chromatin profiling at early stages can predict developmental outcomes of both IVF and
SCNT embryos. These goals will improve the efficiency of generation of agricultural and biomedical animal
models and establish strategies and insights for human clinical applications.

Public health relevance
PROJECT NARRATIVE The overall objectives of the current proposal are to: 1) gain a thorough understanding of the epigenetic, chromatin, and transcription differences between IVF and SCNT embryos and a mechanistic understanding of the factors that define the chromatin/epigenome landscape and control the onset of transcription in early embryos; and 2) test new approaches to correct reprogramming defects and improve SCNT development both in preimplantation and postimplantation embryos, and develop a diagnostic to allow selection of developmentally competent SCNT embryos. This research will have a large impact on expanding fundamental knowledge of molecular processes that underlie human and animal reproduction, which are also highly relevant to reprogramming in embryonic stem cells and induced pluripotent stem cells. Moreover, the research will lead to innovative mechanistic approaches for eliminating adverse outcomes associated with cloning in farm animals.